Equipment Supplement on NEI U24 EY-029890

!* * * & + % ,)# ) +!% &) ) +!%# '! $ %+ '!+ #!,$ ,* *,*+%+!# %,$ ) & *! + !$'!)!% !*&) )* $%0 & . ! # +& + % )+!&% % + & ' &+&) '+&) ##* %,$ ) & %+,)##0 &,))!% !% )!+ ) +!%# % )+!&% !* * * - % ! %+! ! !% & * + + ) +), &$&#& , * & ,$% !* * * ,) ) * ) + $ * % !%*+),$ %+# !% $&%*+)+!% + + $ !+ % + )'0 &) + ) +!% !% %!% !* * $& #* '#0* )!+!# )&# !% + +)%*#+!&%# &%+!%,,$ 0 ' )$!++!% )'! &*+ +!- % #!%!##0 ) # -%+ ** **$ %+ & + )' ,+! ) *'&%* * % #&% + )$ &,+&$ * & ) +!%# % + )'0 &. - ) + *, ** & ')!&) % + )'0 +)!#* ' % &% + ') * % & -!# # !+ !* * +) + ##* % &%+)*+ + *,*+%+!# #&** & +) + ##* !% -% .!## ) (,!) + )' ,+! *+)+ ! * + + ' )$!+ ) % )+!&% &) ) '# $ %+ & ' &+&) '+&) ##* % ) *+&)+!&% & % ,)# &%% +!-!+0 & $& #* & ,$% ) +!%# !* * * % ')&-! + &,% +!&%# %&.# % &) ' &+&) '+&) ) '# $ %+ + )'! * +& !$')&- -!*,# ,%+!&% * *' ! ! !% + - ** $# + $ & !%- *+! +&)* .!+ /' )+!* !% % ,)# ')& %!+&) % '#,)!'&+ %+ *+ $ ## !&#& 0 ) +!%# ## ! ) %+!+!&% !% )!+ ) +!%# !* * '+ &#& 0 % + )'0 % ,%+!&%# %#0*!* & /' )!$ %+# +) +$ %+* !%- *+! +&)* - + /' )+!* +& ** ** + )' ,+! ) *'&%* * % +& - #&' '')&')!+ &,+&$ $ *,) * +& -#,+ * +0 % !0 - !+ ) +!%# !* * ) * ) !#!+0 +& ) $!%+!% +) + % ** ** & * .!+ &$&#& &,* ,$% ) +!%# !*&) )* ,) &# !* +& - #&' %!% $& #* !% . ! +& !%- *+! + + ) '# $ %+ & ' &+&) '+&)* ,% ) !* * &% !+!&%* & $& #* .!## ,* +& ! %+! 0 0 ')$ + )* & ## +)%*'#%++!&% % ) +$ %+ % ! ) %+!+!&% + + .!## )!+!# &) *+, ! * & !* * *' ! ! ''#!+!&%* & ) % )+!- $ !!% &) + ) +!% 0 ')&' )+! * +& *+, ! ) ' 0*!# +)%*'#%++!&% ')$ + )* !*+)!,+!&% & &%&) ##* .!+ !% + &*+ ) +!% &%&) ## ! ) %+!+!&% % *,)-!-# ## &%% +!-!+0 % ,%+!&%#!+0 .!+ !% + ) +!% &%% +!-!+0 +& + -!*,# '+ .0* !% + )!% % ')& **!% % -!&)# **0* &) -!*!&% )%*'#%++!&% .!## *+, ! !%!+!##0 ,*!% / %& ) +* & . ## )+ )!1 % ) !#0 -!## ,$% ' &+&) '+&) ') ,)*&) ##* )&$ &% #!% + + ')& , * )& * % &% * % %&+ ) #!% & )& *' ! ! ') ,)*&) ##* &%,)) %+#0 . .!## - #&' .!+ !% *' ! * *0*+ $ &) ' &+&) '+&) ) '# $ %+ 0 ! ) %+!+!% %!% ! * !%+& )& &% % )& *' ! ! ') ,)*&) ## #!% * +& ) '!+,#+ ' &+&) '+&) ## ) '# $ %+ + + .&,# &,) !% ,$% #!%!# +)!#* ,*!% ,$% ##* % - #&' + ') ,)*&) ## #!% +)%*'#%+* .!## %#01 &) !%+ )+!&% % ,%+!&%#!+0 !% !* * & $& #* !% . ! ! ) %+!+!&% !%+& % . ' &+&) '+&) ##* % !%- *+! +